Health systems innovations for supporting transitions of care for incarcerated people living with HIV, hepatitis C and opioid use disorder

PROJECT SUMMARY / ABSTRACT
Recently incarcerated adults have a high risk of death from opioid overdose and frequently report HIV/HCV
transmission risk behaviors, making them a high priority group for health system-based interventions aimed at
improving engagement in primary care and utilization of evidence based prevention and treatment services.
This project will comprehensively evaluate post-incarceration health care utilization and outcomes for low-
income residents with opioid use disorder, HIV and HCV by linking patient-level data from a large prison
system and Medicaid enrollment and claims records for a Midwestern U.S. state that has been heavily
impacted by the opioid epidemic. The integrated data will then be used to pursue three complementary
research aims: 1) To identify individual-level characteristics and comorbidities influencing use of general
outpatient care by people with chronic health conditions after they are released from prison; 2) To assess the
impact of a systems-level intervention, facilitated pre-release Medicaid enrollment, on the use of post-release
outpatient care; and 3) To adapt and evaluate the feasibility and acceptability of a low cost, evidence based
transitional care program, called C-TraC, for increasing use of outpatient medical care for incarcerated people
with HIV, HCV and/or opioid use disorder. We propose a mixed-methods approach, based on the Replicating
Effective Programs (REP) Implementation Theory Model, to adapt a telephone-based, nurse-led case
management intervention (C-TraC) for the correctional health care setting. Through key stakeholder interviews
and focus groups, we will elicit the perspectives of incarcerated patients, correctional officers and
administrators, and prison-based social service and health service providers, in order to develop an adapted C-
TraC protocol reflective of locally defined goals and outcomes. Implementation of the C-TraC program across
the state prison system will proceed through several rapid-cycle improvement phases, resulting in stakeholder-
driven modifications designed to optimize fidelity to core protocol steps and achievement of targeted outcomes.
This protocolized implementation approach, together with the novel data resource created through this project,
will allow our team to define the optimal target population, staffing requirements and associated costs, and
preliminary measures of health impact that will be needed to disseminate the C-TraC to other prison systems,
and to conduct a clinical trial to formally assess its effectiveness. If found to be effective in this setting,
transitional care interventions such as C-TraC could have a profound public health impact by promoting access
to evidence-based opioid treatment for one of the most vulnerable populations in the U.S.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE People who are living with or at high risk for HIV, hepatitis C and opioid use disorder are incarcerated more frequently than the general population, and face substantial challenges accessing needed treatment and prevention services after they are released from prison. This project will examine the critical components necessary for ensuring effective transitions of care after release from prison, evaluating the influence of individual-level characteristics and comorbidities, and community-level determinants such as local health systems capacity for delivering medication assisted treatment for opioid use disorder and hepatitis C treatment. We will analyze linked data systems from the Wisconsin Department of Corrections and the Wisconsin Medicaid Program to determine whether policy changes aimed at increasing Medicaid coverage for low-income residents have translated to improved healthcare access for this population. Lessons learned from these analyses will inform the adaptation and implementation of a low-cost, nurse case management intervention to more effectively link people to post-incarceration care and services.